Role of histotripsy synergized CD40 signaling in the re-engineering of cold tumors

Project Summary
Advanced-stage metastatic melanoma is the deadliest form of skin cancer, typically resistant to chemo- and
radiotherapy. For such patients, the advent of immune checkpoint inhibitors (ICIs) has been a revolutionary
change, improving tumor remission and survival rates, reversing prior lack of progress. Although promising, a
large proportion of patients, especially those with poorly immunogenic ("cold") tumors, show only modest
response to ICIs, and even responders relapse frequently. New tumor-reengineering technologies are urgently
needed to improve survival rates in patients with immunoresistant cold tumors. The objective of this project is to
optimize an innovative combinatorial therapy based on local focused ultrasound-based histotripsy (HT) and anti-
CD40 agonist antibody (aCD40) encapsulated polymeric microparticles (CMPs) to reprogram cold melanoma
tumors. HT non-invasively and rapidly generates acellular antigen depots with sharp boundaries in solid cancers,
while aCD40 activates antigen-presenting cells (APCs). Our murine melanoma studies found that CMP is more
efficacious compared to soluble aCD40 alone, and when combined with ICI/HT achieves complete remission of
untreated tumors. Based on this premise, we will test the central hypothesis that intratumorally-administered
CMPs that serve the dual functions of tumor antigen capture and sustained CD40 activation with HT will achieve
durable remission of locally-treated and remote untreated melanomas. To test our hypothesis, the aims are to
1) Determine efficacy of the HT and CMP combined regimen in murine tumor models varying in immunogenicity
and burden, 2) Elucidate ICI resistance reversal mechanisms that drives abscopal effects with HT and CMP,
and 3) translate our findings to clinical trials in dog veterinary patients with spontaneous malignant melanoma.
Dog melanoma resembles human melanoma, and metastasizes aggressively, and is advantageous for
assessing translatability of our combinatorial therapy. Transforming immunologically “cold” tumors to
immunogenic ones in advanced stages of cancer is a challenging goal. The project results will enable rapid
activation of cold melanomas by locally generating large tumor antigen depots that can synergize with CD40
signaling to improve efficacy against locally treated and distant untreated tumors. Our studies in clinically-
relevant models will inform feasibility of improving survival in a large proportion of metastatic melanoma patients
with immunotherapy-resistant tumors.

Public health relevance
Narrative Immunosuppressed solid tumors are highly aggressive and resistant to available immunotherapies. This project will investigate a new combinatorial therapy in mouse tumor models and dog patients with spontaneous melanoma, using a locally-applied focused ultrasound to release tumor antigens and an intratumorally administered microparticle to synergistically enable activation of CD40 pathways for durable clearance of both locally-treated and untreated melanomas. Success of this project can be highly significant for patients who fail to respond effectively to existing immunotherapies, thereby improving their survival rates.